EnhAncing Research and meNtoring Skills in Tuberculosis (EARN TB)

PROJECT SUMMARY
Despite the advent of new diagnostics and treatments, tuberculosis (TB) remains a leading cause of overall
mortality worldwide. There is an urgent need to better understand the host immune response to
Mycobacterium tuberculosis (Mtb) and its role in causing lung damage and lung health morbidity as well as to
train the next generation of TB scientists focused on patient-oriented research. The overarching goal of this
K24 is to provide support for Dr. Russell Kempker to 1) have the protected time needed to successfully mentor
early-stage investigators in TB patient-oriented research, 2) receive training in host immunology and
bioinformatics as well as in team science, mentorship, and leadership and 3) to carry out innovative TB
translational research on the host immune response to Mtb. Dr. Kempker has mentored >60 U.S. and
international trainees in TB patient-oriented research and has leadership positions in numerous TB research
capacity building programs including serving as the Co-Director of the NIH NIAID supported Emory/Georgia TB
Research Advancement Center (TRAC) Developmental Core and MPI and Associate Program Director of two
Fogarty International Center D43 Global Infectious Diseases TB Research Training Programs in the countries
of Ethiopia and Georgia, respectively. The proposed research will leverage a long standing (>20 years)
collaboration with the National Center for Tuberculosis and Lung Diseases in Tbilisi, Georgia including
leveraging an ongoing NIAID R01 study (Contact PI, Kempker; R01AI173946) to conduct the proposed
research and to provide mentored research opportunities. This K24 would utilize a unique cohort of persons
with pulmonary TB undergoing adjunctive surgical resection to support new studies including 1) evaluating the
impact of surgical removal of Mtb diseased lung on decreasing systemic inflammation and 2) utilizing
enhanced spatial transcriptomics methods to evaluate the host immune response associated with various
types of lung granulomas at a single cell level. Findings from this newly proposed research are expected to
provide critical insights that can inform strategies for developing novel host directed therapies. Emory
University provides an excellent environment for achieving the training goals for this K24 proposal and through
it various schools and international partners for the recruitment of a diverse, strong pool of early-stage
investigators. Overall, this proposal would directly address key research priorities in the NIAID TB strategic
research agenda and provide Dr. Kempker the time, training, and skills to effectively mentoring the next
generation of impactful TB scientists in patient oriented clinical and translational research. The long-term goal
of the proposed activities in this K24 proposal are focused on improving the lives of persons inflicted with and
suffering from TB and to provide meaningful contribution in the fight to end TB.

Public health relevance
PROJECT NARRATIVE Tuberculosis remains an enormous public health problem responsible for substantial morbidity and mortality worldwide; innovative tools and a new generation of investigators are needed to end this epidemic. This proposed K24 award would support Dr. Russell Kempker to mentor early-stage investigators in the U.S. and internationally to carry out clinical and translational patient-oriented research. The focus of the proposed research is to gain critical insights into the host inflammatory response at the site of disease and to evaluate the impact of Mycobacterium tuberculosis on systemic inflammation with a long-term goal of developing novel host directed therapies and improving health outcomes during and after tuberculosis treatment.